Regulation of Heterotrimeric G proteins by non-receptor activators

Summary/Abstract:
Heterotrimeric G proteins are the major intracellular enzymes that receive signals from plasma membrane G
protein coupled receptors (GPCRs) and transduce them to a broad array of intracellular effectors. Our lab has
contributed much to the understanding of the function of a pair of G protein regulators, Ric-8A and Ric-8B. We
identified Ric-8A and Ric-8B as G protein  subunit binding proteins and showed that they possess the ability
to accelerate the rate at which G subunits release GDP and bind GTP. This activity is similar to GPCR action
towards G protein heterotrimers. GPCRs stimulate G protein GDP/GTP exchange for the purpose of activating
the G proteins to transmit signals. We have yet to find conclusive evidence that Ric-8 proteins facilitate G
GDP/GTP exchange for signaling purposes. We did find that deletion of the Ric-8A or Ric-8B genes in mice
caused embryonic lethality. Culture of Ric-8A or Ric-8B knockout embryonic stem cells that were attained from
viable embryos prior to death demonstrated that the cells had dramatically reduced levels of G proteins. This
prompted our investigation into the role that Ric-8 proteins have in regulating G protein abundance. We found
that Ric-8 proteins are molecular chaperones that facilitate protein folding of newly made G subunits. When
G proteins are made in cells lacking Ric-8 proteins, they are misfolded and rapidly degraded. We reconcile the
in vitro GDP/GTP exchange stimulatory activity of Ric-8 with the folding function by proposing that Ric-8
proteins bind the intermediate of the in vitro exchange reaction in cells, newly-synthesized, nucleotide-free G
proteins to facilitate first time GTP binding. Until now, all evidence indicated that Ric-8 proteins acted
constitutively to fold G proteins. The premise of this new application is based on our recent data that show that
Ric-8 activities are subject to dramatic regulation by post-translational phosphorylation. We will investigate a
new link between mitogenic oncogene stimulus that leads to Ric-8 deregulation (dephosphorylation) and
possible remodeling of cellular G protein levels. We have made important strides in our long-time collaborative
efforts to investigate the structural basis by which Ric-8 proteins regulate G proteins. The work in this
application will define the way that phosphorylation regulates Ric-8 function.

Public health relevance
Narrative: Heterotrimeric G proteins transduce drug, hormone, and neurotransmitter stimuli into a myriad of physiological cellular actions. Our lab has done much of the work to describe the function of Ric-8 proteins, which are essential regulators for the synthesis of all G proteins. Our current work will investigate a new pathway in which Ric-8 proteins are regulated in pathologic states to alter the levels of G proteins in cells. This may serve a general means to control the tone of total cellular G protein signaling.